Spatiotemporal Optimization of Deep Brain Stimulation for Parkinson's Disease

PROJECT SUMMARY AND ABSTRACT
The basal ganglia have a rich somatotopy and functional topography composed of motor subcircuits that are
thought to be critically important to the pathophysiology of Parkinson's disease (PD) and successful application
of deep brain stimulation therapy (DBS) for managing each cardinal motor sign of PD. There is a strong clinical
need to better understand these processes and in turn harness them to deliver therapy that is tailored to a
patient's own symptomatology and motor control needs on a moment by moment basis. This project will
investigate how spatiotemporal optimization of DBS settings can differentially affect neural pathway activation
through the brain's motor control network and how those results translate to improving each of the four cardinal
motor signs of PD (bradykinesia, rigidity, tremor, and postural instability). Aim 1 will investigate at the single
cell, ensemble, and network levels how spatiotemporal parameters of DBS influence information transmission,
and critically how the motor control network is able to produce naturalistic movements despite information
lesions induced by high-frequency stimulation. Aim 2 will develop and apply a Bayesian Dual Adaptive Control
algorithm to investigate how spatiotemporal DBS settings affect electrically-evoked compound action potentials
and how those features map onto modulating individual motor signs. Aim 3 will leverage the ground-truth
electrophysiological data from high-density microelectrode array recordings at the site of DBS and within the
motor control network to validate key parameters used in computational models of neural pathway activation
with DBS therapy. The proposed study integrates innovative high-density microelectrode array recordings,
closed-loop optimization algorithms, micron-resolution anatomical pathway imaging, and subject-specific
computational models of DBS. Together, this project will enhance our understanding of the pathophysiology of
PD and provide critical data towards translating next generation personalized and responsive DBS therapies.

Public health relevance
NARRATIVE Deep brain stimulation (DBS) for Parkinson's disease is a complementary neurosurgical treatment to dopamine replacement therapy aimed at providing more consistent motor control. This consistency, however, depends on how well stimulation settings are optimized for a given patient during a clinical visit (personalized therapy) and how well they can adapt to meet the motor control needs of the patient at any given moment (responsive therapy). This project will investigate how spatiotemporally optimized DBS settings differentially affect the four cardinal motor signs of Parkinson's disease (bradykinesia, rigidity, tremor, and postural instability) and how those behavioral changes relate to neural pathway activation through the brain's motor control network.